Core B: Biostatistics / Bioinformatics

CORE B BIOSTATISTICS AND BIOINFORMATICS – PROJECT SUMMARY
The Biostatistics and Bioinformatics Core (BBC) provides statistical, and bioinformatics, and computational
biology collaboration and data management support for each of the Hepatobiliary Cancer (HBC) SPORE
projects, developmental research and career enhancement projects, pilot projects and the other cores. The
BBC has been active in preparing the statistical plan for each of the four projects in this application related to
study design, analysis, and bioinformatics needs. The BBC builds upon the innovative and time-tested
procedures and systems developed by Mayo Clinic, one of the largest statistical groups in the country whose
members have collaborated on more than 13,000 clinical and basic science research studies since 1966. In
the upcoming funding period, the Specific Aims of the BBC are as follows:
Aim 1. Provide statistical and bioinformatics collaboration for each of the HBC SPORE projects, the
developmental research program projects, the career enhancement program projects and the cores. We will
provide statistical and bioinformatics support across different fields, including clinical trials, basic sciences
including translational and immunologic correlative studies, sequencing and mutation discovery, expression
analysis and genomics, and information management.
Aim 2. Provide management and integration of existing and newly collected data through consistent and
compatible data handling. Areas of support will include database development, data forms development and
processing, data collection and entry, data archiving, quality control, and management of information relating to
gene mutation identification. All of the clinical trials proposed in this application will take advantage of the
extensive infrastructure available to trials through the Mayo Clinic Cancer Center (MCCC), With multiple types
of molecular and genomic measurements already processed through the Cancer Genome Atlas (TCGA), we
will develop a centralized database to organize processed level-3 molecular and genomic data, and connect
these data with a registry database for detailed clinical records, follow-up information, and availability of
tissue/blood biospecimens.
Aim 3. Provide support to the Biospecimen and Pathology Core in providing biospecimen resources to the
research community. Through this support we aim to provide efficient and prompt access to the biospecimen
resources for HBC investigators. Biospecimen resources will also be connected to data management and
centralization system described in Aim 2 to facilitate collaboration and data reuse across the HBC SPORE.

Public health relevance
CORE B BIOSTATISTICS AND BIOINFORMATICS – PROJECT NARRATIVE The Biostatistics and Bioinformatics Core collaborates with HBCs SPORE investigators in designing studies and clinical trials, determining optimal data collection methods, performing data management and quality control, and in analyzing and interpreting study results. The Biostatistics and Bioinformatics Core interacts with the Biospecimen and Pathology Core, ensuring optimal use of resources and outstanding quality research with the utmost reliability.